Developmental pathways and treatment of OCD and anorexia: the role heightened performance monitoring and overcontrol

Project Summary/Abstract
Anorexia nervosa (AN) is one of the deadliest psychiatric illnesses, and prognosis is worsened when comorbid
with obsessive-compulsive disorder (OCD). Further, childhood OCD typically onsets before AN, indicating a
possible developmental trajectory with childhood OCD preceding and predicting AN onset. Therefore,
identifying and characterizing the mechanisms that underly the AN/OCD developmental progression and
AN/OCD comorbidity is imperative for developing effective, targeted interventions for these difficult-to-treat
psychiatric presentations. The overarching aim of this proposal is to use both a large, longitudinal, community
dataset and a real-world clinical sample to (a) examine the developmental trajectory of AN/OCD comorbidity,
including specific mechanisms that could be targeted in treatment and (b) examine a mechanism-based
psychosocial treatment for this comorbidity. Results will help identify at-risk individuals and inform the
development of targeted and effective transdiagnostic interventions. This project will also achieve the following
training goals: (1) develop expertise in childhood development of AN and OCD psychopathology, (2) gain
expertise in clinical translational work, (3) learn advanced analytic techniques and data science skills, (4) gain
skills to be an independent investigator, including training in scientific rigor and reproducibility, professional
development, and scientific communication. The assembled training team has extensive expertise in AN, OCD,
treatment research, and advanced statistics, and will support the applicant in developing the skills and
knowledge needed to achieve her career goals of developing an independent program of research examining
AN/OCD psychopathology and treatment.

Public health relevance
Project Narrative The comorbidity of anorexia nervosa and obsessive-compulsive disorder is especially difficult-to-treat, with a poor prognosis. This proposal aims to investigate the developmental trajectory of AN/OCD comorbidity, including specific mechanisms of AN/OCD comorbidity that could be targeted in treatment, and examine a mechanism-based psychosocial treatment for these psychiatric presentations. The overall goal of this line of research is to identify at-risk individuals and help to inform the development of targeted and effective transdiagnostic interventions.